Molecular determinants of Salmonella cell-envelope copper homeostasis

Project Summary
The goal of this proposal is to define the mechanisms of Cu homeostasis in the cell envelope of the
pathogen Salmonella enterica. This organism is an important and frequent cause of gastroenteritis, as
well as, systemic infections. Cu is required as a redox co-factor in the catalytic centers of enzymes.
However, free Cu is highly reactive and deleterious to cells. Cu, along with the oxidative burst, is central
in host-pathogen interactions as part of the innate immune response. As such, redox/Cu homeostasis is
essential for bacterial virulence. While there has been significant progress in identifying cytoplasmic Cu
homeostatic mechanisms, there is a lack of understanding of how the cell envelope handles and
distributes Cu, whilst maintaining the associated redox balance. Our goal is to define and model the Cu
distribution in the Salmonella cell envelope and identify its molecular links with the redox stress response.
The aims of this proposal are: 1) Quantify Cu fluxes and equilibria among periplasmic, cytoplasmic and
external compartments while defining the size and identity of the periplasmic Cu sink pool. 2) Define the
role of CueP as the periplasmic Cu chaperone exchanging the metal with various targets. We will monitor
CueP in vivo abundance, as well as its apo/holo equilibria, in response to changes in periplasmic Cu
levels. We will determine how CueP obtains Cu from membrane transporters in the inner and outer
membranes and delivers it to alternative carriers to achieve steady state levels of periplasmic Cu. CueP
participation in the metallation of several periplasmic cuproenzymes will be assessed. 3) Determine the
role of the ScsABCD system at the interface of Cu- and redox-homeostasis. The redox activity of these
enzymes will be determined and in vivo substrates identified. The relation between ScsABCD activity and
Cu binding to substrates or among ScsABCD enzymes will be established. To achieve these aims, the
joint efforts of two laboratories with complementing expertise will use a combination of approaches
(modeling of metal fluxes, proteomics, metallomics, in vitro host/pathogen interaction). Our approach to
systematically elucidate the mechanisms of Cu/redox homeostasis in the envelope of an important
human pathogen is novel, timely and innovative.

Public health relevance
Project Narrative The proposed research will increase our understanding of how Salmonella enterica tolerates and distributes copper. Copper, as part of the innate immune response, is used as a bactericide agent by the human host to control/restrict/limit Salmonella infection. The links between copper and periplasmic redox stress response will be also identified. The proposed studies are relevant to public health because Salmonella enterica causes gastroenteritis and systemic diseases in humans.